Effects of early-life nutritional supplementation on the brains, bodies, and behaviors of Ghanaian youths in middle adolescence

PROJECT ABSTRACT
An estimated 250 million children in low- and middle-income countries are at risk of not fulfilling their
developmental potential, partly due to undernutrition. The long-term goal of this proposal is to inform evidence-
based programs and policies to support children and adolescents in Ghana and other low- and middle-income
countries to grow and develop to their full potential. This proposal is to conduct a follow-up study of youth at
14-16 years whose mothers participated in a randomized controlled trial providing small-quantity lipid-based
nutrient supplements (SQ-LNS) to pregnant women from ≤ 20 weeks of gestation through 6 months
postpartum and to their infants from age 6 to 18 months (n = 440), comparing outcomes to youth from the
control groups whose mothers received micronutrient capsules during pregnancy and postpartum (n = 880)
without additional supplementation to the infants. Under protocol R01HD099811, we enrolled 979 children at
10-12 years in assessments of brain and body maturation, autonomic regulation, adrenocortical and
adrenogonadal hormones, and behavioral and psychosocial functioning. Benefits of SQ-LNS, directly and in
the context of home environment quality, were evident in white matter microstructure, height, pubertal
development, and other measures. We seek to document the long-term effects of SQ-LNS on brain and
nervous system development and biobehavioral functioning in middle adolescence, a pivotal period marking
the onset of multiple mental and physical health problems. The specific aims are 1) To investigate the long-
term effects of SQ-LNS on physical maturation, as seen in brain structure, height, and pubertal development;
2) To examine the emergent effects of SQ-LNS on brain function, autonomic regulation and hormonal activity
in middle adolescence, both directly and in the context of quality of home environments; and 3) to show the
neurobiological mechanisms through which SQ-LNS promotes psychosocial and cognitive competence and
buffers the effects of disadvantaged environments on youth’s social-emotional difficulties. The hypotheses are
that, compared to youth who did not receive early SQ-LNS, youth in the SQ-LNS group will H1) have better
white matter microstructure, be taller, and have normatively timed pubertal milestones, and H2) evince
stronger prefrontal cortex regulation of subcortical regions, more flexible autonomic regulation, and lower
chronic cortisol levels, especially when raised in less advantaged home environments. Further, H3)
intervention group differences in neurobiological structure and functioning are expected to mediate group
differences in social-emotional development. This study will be the longest follow-up study in Africa of a RCT of
pre- and post-natal nutritional supplementation covering most of the first 1000 days of life following conception.
This study represents an unprecedented opportunity to examine the enduring and emergent effects in middle
adolescence of a novel nutrient supplement in early life using a RCT design, and the underlying neural
mechanisms of the effects of early nutrition on later adjustment and well-being.

Public health relevance
PROJECT NARRATIVE The proposed study will add to the growing evidence base for the effects of nutrient supplements during early life to promote long-term healthy maturation and document the enduring return on investment in maternal and child nutrition programs, to inform evidence-based health policy in Ghana and other low- and middle-income countries. By demonstrating anthropometric, neurobiological, and behavioral benefits in middle adolescence from improved nutrition during pregnancy and early childhood, this study would provide strong support to calls to invest in maternal and child nutrition as a prevention strategy to reduce the costs incurred on the health care system. Hence, this study will be in accordance with the World Health Organization’s Mental Health Action Plan 2013-2030 which highlights the critical need to implement strategies for prevention and strengthen information systems, evidence, and research.